Omega-3 fatty acids induce macrophage IL-22 signaling to promote resolution of dust-induced lung inflammation

PROJECT SUMMARY
Inhalation of aerosolized dusts from urban, rural, and farming environments can trigger harmful airway
inflammation and injury; over time, continual exposure to these particulates increases one's risk for developing
inflammatory airway diseases. While dust exposures negatively impact lung health, factors contributing to
protection versus susceptibility to lung disease following these continual inhalational exposures are unclear. A
recently discovered class of specialized pro-resolving lipid mediators (SPM) derived from omega-3 fatty acids
regulate lung inflammation, immunity, and repair, and are likely key to the beneficial effects of diets high in
omega-3 fatty acids. Our previous investigations identified that the omega-3 fatty acid docosahexaenoic acid
(DHA) and its lipid metabolite maresin-1 (MaR1) mitigate airway inflammation from acute and repetitive organic
dust exposure, mediated in part by macrophage activation and pro-repair activities on the airway epithelium.
Our exciting new data identify that omega-3 fatty acids and MaR1 can activate IL-22 signaling in lung
macrophages. IL-22 signaling promotes mucosal immunity and epithelial barrier integrity, and its activation in
the presence of these bioactive lipids may be key to their protective effects. Furthermore, our novel finding of
IL-22 signaling in macrophages challenges current dogma regarding the activation and regulation of this
pathway. The goal of this proposal is to investigate the role of omega-3 fatty acids in promoting pro-repair IL-22
signaling in the lung following dust exposures. We hypothesize that omega-3 fatty acids and SPM promote
lung recovery following particulate matter exposures by inducing alveolar macrophage IL-22 production that
subsequently promotes alveolar macrophage pro-resolution polarization and lung epithelial repair. To test this
hypothesis, in Aim 1, we will establish the impact of omega-3 fatty acids and IL-22 on lung recovery following
dust exposure. In Aim 2, we will evaluate the role of omega-3 fatty acids and IL-22 in epithelial repair and
mucosal immunity during dust exposure. In Aim 3, we will identify how SPM and IL-22 signaling impacts lung
macrophage polarization. Together, our studies will identify how omega-3 fatty acids modulate susceptibility
versus resilience to dust exposures, including a novel protective mechanism via activation of macrophage IL-
22 signaling to promote tissue repair and mucosal immunity. We expect our studies' findings to guide novel
treatment strategies for lung disease.

Public health relevance
PROJECT NARRATIVE Chronic exposures to environmental dusts lead to lung inflammation, injury, and disease. The overarching goal of our studies is to determine how dietary omega-3 fatty acids promote resolution and repair in the lung following dust exposure through regulating macrophage-derived IL-22 signaling. These studies support NIH goals by increasing our understanding of how particulate matter inhalation impacts lung inflammation, and exploring strategies for promoting recovery from these inflammatory exposures to protect against disease.